BIOLOGY AND MOLECULAR BIOLOGY OF HEPATITIS C VIRUS

Full length HCV clones have been produced and shown to be infectious upon transfectin directly into chimpanzee livers. Two chimps were inoculated and both developed HCV infections and disease typical of HCV in chimpanzees following IV inoculation of infectious serum. Both these animals have become chronically infected. As both these animals were infected with clonal virus that was of a single uniform sequence, detailed analyses of the evolution of this virus was possible. It has been claimed that mutations in the hypervariable region of E2 result in escape mutants and allow the persistent infection. We have shown that mutations in the so called hypervariable region of the E2 envelope glycoprotein are not responsible for the maintenance of the persistent infections. Both animals deveoped anti HCV antibody including antibody to the two envelope glycoproteins , E1 and E2, and the the HVR at the amino terminus of E2. The virus in both chimpanzees showed some variabllity over a one year period of observation. After 2 1/2 years of observation, the virus in these chimpanzees has continued to evolve at a slow rate. One additonal mutation has occured in the hypervariable regions of the virus in each animal. however, it is believed that these changes are not sufficient to result in immune escape. A series of mutants have also been created in the infectious clone and tested for viability. As predicted none of them was viable though they may have primed the immune system. A second infectious clone representing genotype 1b virus has been prepared and will soon be tested in a chimpanzee.